Ecological and evolutionary causes and consequences of host heterogeneity induced by prior exposure

This attachment is not required by the FOA, this placeholder is just to resolve system errors.

Public health relevance
This attachment is not required by the FOA, this placeholder is just to resolve system errors.